Translational Interdisciplinary Research Training in Communication Sciences and Disorders

Project Abstract
This training grant is designed to address four critical threats to the field of Communication Sciences and
Disorders (CSD): (1) a national shortage of PhD level researchers; (2) increased need for translational,
interdisciplinary, and cross-methodological training; (3) gaps in the implementation of scientific advances to
educational, healthcare, and community settings; and (4) lack of equity and inclusion in the profession
including in research protocols and implementation of services to under-served communities. This proposal
requests support for four predoctoral students to participant in a translational and interdisciplinary training
program that draws on faculty from the departments of Communication Sciences and Disorders, Psychology
and Human Development, Otolaryngology, Biostatistics, and Medicine and leverages the resources and
training opportunities available at Vanderbilt (e.g., Vanderbilt Institute for Clinical and Translational Research,
The Implementation Science Core, The Office of Health Equity). Vanderbilt is uniquely positioned for the
proposed research as it is a recognized leader the fields of CSD, translational and implementation research,
and health equity. The purpose of this training grant is to prepare students for independent scholarship in
translational and interdisciplinary research. Trainees take formal coursework across different disciplines,
including instruction in quantitative methods, gain hands on experience with multiple methodologies, complete
a collaborative-interdisciplinary research rotation (spanning two or more approaches), in addition to working in
the lab of their primary advisor. Trainees have access to a number of research programs including in auditory
neuroscience, pediatric audiology, cochlear implants, language development and disorders, language
neuroscience and rehabilitation, psycholinguistics, developmental disorders and disability, cognitive-
communication disorders, community health, genetics, reading and reading disorders, acquired brain injury,
hearing and hearing aids, motor speech, voice, and fluency. Experimental methodologies include animal
models (e.g., monkey, mice, rabbit), neuroimaging (e.g., MRI/fMRI, DTI, fNIRS, EEG/ERP), physiological
measurement (e.g., heart rate, respiration, skin conductance), computational modeling, eye-tracking,
neuropsychology, lesion method, various behavioral paradigms, electromagnetic articulography, and advanced
statistical approaches. Students participate in expanded training in responsible conduct of research, replication
and reproducibility, scientific communication and grant writing, journal clubs, and research colloquia. Key
outcomes include submission of peer-reviewed manuscripts, application for external research funding (e.g.,
NIH NRSA F31), participation in national or international meetings, and eventually, employment at a research
university. The overarching goal of the training program is to prepare a number of highly trained and qualified
researchers who are well-equipped to address the challenges facing the field of CSD.

Public health relevance
Project Narrative This program provides a uniquely translational and interdisciplinary training opportunity for scientists in the field of Communication Sciences and Disorders. The training is designed to address critical challenges facing the field including a national shortage of PhD level researcher, increased need for translational, interdisciplinary, and cross-methodological training, and a lack of training in implementation science and health equity. The overarching goal of the program is to prepare a number of highly trained and qualified researchers who are well-equipped to address the challenges facing the field of Communication Sciences and Disorders.